Innate and Hormone-Mediated Sex Differences in Extracellular Matrix Remodeling

PROJECT SUMMARY
Biological sex is a clear factor in an individual’s ability to repair and regenerate tissue. Females are at higher
risk for soft tissue injuries compared to age-matched males and exhibit higher rates of degenerative diseases
such as osteoporosis, sarcopenia, osteoarthritis, and carpal tunnel syndrome. One common hallmark of these
degenerative diseases is the disruption in homeostasis of the extracellular matrix (ECM). A delicate balance in
tissue production and breakdown is essential to healthy function in every single tissue. Production of too much
matrix can lead to fibrosis, while excessive matrix breakdown results in weakened tissue function. However,
the role that biological sex plays in the processes of ECM homeostasis are currently unknown. A fundamental
understanding of sex-based differences in tissue remodeling, and the regulation of this process by sex
hormone signaling, will be critical to understanding divergence in injury and disease and establishing patient-
specific regenerative strategies. The overall goal of our research program is to understand how
biological sex regulates the process of ECM remodeling, from initial mechanotransduction to signal
processing to ECM synthesis. Theme 1: Do male and female cells sense their local mechanical environment
differently? There is evidence in many tissues that ECM structure, organization, and resulting function differs
between age-matched males and females. However, the effect this has on cell biology is currently unknown.
Custom-built and commercially available bioreactors will be used to identify differences in the sensing and cell-
level responses to mechanical stimuli based on biological sex alone (isolated cells) and the local environment
(explant tissue and engineered microenvironments). Theme 2: Is the balance of matrix production and
breakdown altered by biological sex? Since degenerative diseases rely on a disruption of the balance between
synthesis and degradation, a broad-spectrum approach to understanding ECM remodeling is necessary. Using
an established model of mechanically-driven ECM remodeling, we can assess synthesis of ECM molecules
and ECM-degrading enzymes, as well as detect products of ECM breakdown in real time. These techniques
will allow for a whole picture of ECM turnover in real time. Theme 3: How does the presence of sex hormones
affect cell signaling pathways associated with ECM remodeling? Dramatic changes in ECM structure during
pregnancy clearly point to a substantial role for hormone signaling in ECM remodeling, and studies
demonstrate a significant role for estrogen signaling in musculoskeletal and cardiac tissues. Using custom-
designed fluid exchange bioreactors, we will have precise control over the concentration and duration of sex
hormones exposure as well as the local mechanical environment simultaneously, allowing us to study the
effect of estrogen and progesterone signaling in different phases of the remodeling process. These studies will
enable a fundamental understanding of the contribution of biological sex to tissue repair capacity and pave the
way for our novel in vitro tools to identify new targets for the development of patient-specific therapeutics.

Public health relevance
PROJECT NARRATIVE Degenerative tissue diseases that disproportionately affect female patients, such as sarcopenia and osteoporosis, are often caused by dysregulation of the delicate balance and regulation of extracellular matrix (ECM) structure. This research proposal will investigate how biological sex and hormonal signaling interacts with the process of ECM remodeling, from the initial sensing of local environmental cues through to final protein synthesis and incorporation, with the ultimate goal of developing novel tools to study sex-specific biology. These studies have broad implications for the treatment of degenerative disorders by enabling the identification and investigation of biomarkers that can be targeted to improve patient-specific therapeutics.